Family-centered integration of social and medical care to promote health equity among children with asthma

Project Summary/Abstract:
Asthma inequitably impacts under-resourced, Black, and Hispanic youth who experience higher asthma
morbidity. These disparities are partially explained by social adversity experienced at multiple levels (child,
family, community). Yet, these critical associations between social adversity and pediatric asthma are not fully
incorporated into strategies to address morbidity among children which may exacerbate existing inequities,
meaning such at-risk children experience decreased quality of life, higher school absenteeism, and decreased
educational and employment achievement in late childhood and adulthood. In this proposal, Dr. Tyris’ objective
is to advance the existing knowledge on social adversity and asthma morbidity with diverse methodologies that
seek to better integrate social care (activities mitigating health-related adverse social factors) into medical care
for children. She will pursue this overall objective through the following specific aims: Aim 1: Predict risk of
hospitalization among DC children with asthma using multi-level social adversity indicators. A population-based
machine learning model using the DC Pediatric Asthma Registry (n= >19,000) and social adversity, clinical,
and demographic data will be developed to predict risk of asthma-related hospitalization and to identify which
variables are most predictive of children at highest risk for hospitalization. Aim 2: Characterize caregiver
perspectives of mechanisms to address modifiable family-level variables that impact child asthma morbidity. A
community advisory board will be established to conduct longitudinal focus groups and engage with caregivers
of children frequently hospitalized for asthma to refine family-level approaches to address social adversity and
enhance recruitment and retention issues for a pilot RCT. Aim 3: Determine feasibility and acceptability of an
integrated social care intervention of individualized assistance and adjustment strategies among caregivers of
children with asthma. Dr. Tyris will conduct a pilot randomized controlled trial to determine if using addressing
social adversity in routine asthma care with assistance (helping resolve social adversity) and adjustment
(modifying health care to overcome social barriers) will be acceptable to caregivers and feasible to implement.
The outlined career development plan, including the proposed aims, will enable Dr. Tyris to gain advanced
training and knowledge in four key areas: machine learning methods for risk prediction, stakeholder-engaged
intervention design, clinical trial design and execution, and integrated social and medical care interventions.
She will leverage the expertise of Dr. Tyris’ mentors (Drs. Teach and Parikh) and advisors (Drs. Trujillo Rivera,
Hinds, and Gottlieb) and the robust, supportive research environment at Children’s National Hospital and
George Washington University. Successful completion of this career development and research proposal will
facilitate Dr. Tyris’ overarching career goal to become an independent and federally funded investigator who
creates, implements, evaluates, and effectively translates stakeholder-engaged solutions designed to mitigate
social adversity, promote health equity, and improve care and outcomes for children with asthma.

Public health relevance
Project Narrative: The proposed research addresses a significant health inequity among children (asthma morbidity) with innovative approaches and will result in a sophisticated machine learning model to identify children at highest risk of morbidity, an engaged community advisory board of caregivers of children with asthma, and critical pilot data on the feasibility and acceptability of an integrated social and asthma care intervention. This work aligns with the NHLBI’s Objective 3 (understanding causes of and identifying strategies to effectively address population health disparities) and 7 (leveraging emerging opportunities in data science to open new frontiers in heart, lung, blood, and sleep disorders). The results of this proposal may enable early identification of children with asthma at risk for hospitalization and a family-centered and caregiver-endorsed integrated social and asthma care intervention which, when paired together, has the potential to improve health equity and reduce morbidity among children with asthma.